Impact of new recipes low in fat, high in carbohydrate on eating habits/diet comp

This research study will attempt to determine if giving a variety of recipes will help people change to a low-fat eating style. The recipes will be given in different ways. We will measure the following: 1. Use of low-fat, high complex carbohydrate (grains, beans, vegetables) recipes at home, 2. Use of low-fat, high complex carbohydrate recipes generally, 3. Eating patterns and diet composition.